Effect of Early-Life Exposure to Metal Mixtures on Lung Function and Mitochondrial DNA in Children

PROJECT SUMMARY
Exposure to harmful toxic metals in utero and during early life is a global health problem. Although millions of
children worldwide are exposed to multiple metals at those times, we still lack convincing evidence of the
impact of metal exposure, particularly mixtures of metals, on childhood lung function. Indeed, most studies
investigated metals individually, but in real life, pregnant women and their children are exposed to many metals
simultaneously, and their combined effects are often unpredictable. Because the human lung develops through
a sequence of highly choreographed processes, ideally, human studies would continuously measure levels of
multiple metals to identify relevant windows of susceptibility.
In this study, we will obtain weekly measurements of multiple metal exposures simultaneously by using
a highly innovative method to measure metal levels in deciduous teeth. Like trees, teeth develop in layers that
trap metals at concentrations commensurate with exposure levels. Hence, each layer is like a time capsule that
contains metal levels from the time it was formed. We will use a validated method to measure 14 metals in
teeth. We can assess exposures cumulatively, as well as at discrete week-by-week developmental windows,
starting prenatally as early as gestational weeks 13-16 up to the time of tooth collection (~6 years). In order to
develop a noninvasive and inexpensive biomarker for later-life lung function, we will combine our analyses of
these metal assessments in teeth with novel blood-based biomarkers that leverage the unique properties of the
mitochondrial DNA (mtDNA), a cumulative biosensor of metal-induced oxidative DNA damage. Our goal is to
use tooth-based, time-specific measures of metals to assess their effects on lung function individually or as a
mixture. We hypothesize that metals adversely affect lung function and that the effects of metal exposures on
children’s lungs are associated with the cumulative damage measured in blood mtDNA.
We can time- and cost-effectively conduct this research by leveraging the infrastructure of the Health
Effects of Arsenic Longitudinal Study (HEALS), a well-characterized prospective cohort of 35,000 adults and
their children in Araihazar, Bangladesh. The proposed study will include 600 children ages 6-10 years. We will
collect at least one deciduous tooth sample from each child and conduct standard lung function tests and
obtain blood mtDNA measures twice, 2 years apart.
We anticipate that findings from this innovative and cost-efficient study will generate information on the
impact of in utero and early-life exposure to multiple metals on pulmonary function in children. Information
generated from this study will appreciably improve our understanding of lung function in response to
environmental metal exposure and ultimately will inform strategies to improve lung function in children.

Public health relevance
PROJECT NARRATIVE Our research will use an advanced tooth biomarker approach to determine 1) accurate timing of exposure to 14 metals—separately and as mixtures, and 2) their developmental windows of susceptibility for lower lung function in late childhood. We will also use blood mitochondrial DNA measures to identify simple and inexpensive biomarkers that reflect cumulative biological effects of earlier exposure to metals and predict children’s lung function specific to metal toxicity. Our research has enormous implications for future research, interventions, and public health policy and will create a model that can be extended to identify additional risk factors for lung diseases, as well as for many other disorders aggravated by environmental pollutants.